URINARY EXCRETION OF BOMBESIN IN CHILDREN WITH CHRONIC LUNG DISEASE

Longitudinal measurements of urinary bombesin in infants with BPD, CF and asthma to assess if elevations parallel the lung injury and repair process or correlate with disease severity.